NARMS Cooperative Agreement Program to Enhance and Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens in New York State

Project Summary TpuhbeliNc ehweaYltohrklabSotartaetoDryepisarctmomenmtitotef dHteoalpthro(tNecYtSinDgOHan)dWimadpsrwovoirntgh tChentheral(tWh Co)f New Yorkers through laboratory testing analysis, investigations and research. TanhteibsipoetcicifircesaismtaonfcethfiosrpSraoljmecotnwelilal baendtoCiampryolvoebadcetercitsionlatoefd, afnrdomsufrovoedillparnocdeufcotrs, psaumrcphlaesefdorfrSoamlmsoenlelclateadngdrCoacemrpyyslotobraecst.erOubtijleicztinivgesmwicirlol bieolotog:ic1a)l tceosltles;ct2)ancodlltecst, asenraolytyzpeinagnadnaelxycshisa;n3g)eshsiuprv1e0i0ll%anocef SadlamtaonoenllaiasonldatCeamidpeynlotibfiacateironisolanteds aptrtoaivnidede fCreonmtermfeoartVesatemripnlaersyfMoredaidcdiniteio(nCaVlMt)e,sNtiAnRgMtoS aFnDdAs;tatnedla4b)orcaotlolrayboprartenewrsi.th FDA, OamutocuonmteosfeSxaplemcotendellfaroamndthCisamwpoyrlkobinactluerdei:so1l)atpersofvriodmingreatnaiilnmcreatse tihnathceantotbael aenxcahlyaznegde; i2n)fomrmaianttiaoiniangdthtestabreilsiutyltst;o3c)opmrpoavrideinregsaunltsintcoresausreveinilltahnecenudmatbaeranodf cisollabteosraotfioCnamanpdylcobmacmteurniacnadtioSnalamoonnegllapasrutbnmeriitntegdentotitihees. FDA; and 4) increased

Public health relevance
Project Narrative TadhveaNnceiwngYtohrek hSetatlethDoefpNaretwmeYnotrkoef rHsetahlrthou(gNhYSaDcOoHm)phreahsebneseivneanletawdeorkinofprpoutbelcitcinhgealnthd acntdivistuiebsuarnbdansearvreicaes,.Tthecdoivmeprsleitxyityooffthestate,fwroimthdrenspelyctpotopurlatced,uertbhannic,itoy,ruarnadl sgocvieorencothneomstiactset’astpuus,bwlicarhreaanltshaspuucbceliscshfuelalylt.h TsyhseteNmYSthDaOtHisicsosmeepkreinhgenfusnivdeinagndtofleimxipbrleovtoe diseotleactteidonfromf, afonoddspurovdeiullcatns cpeurfochr,aasendtibfriomticrreetasisl tgarnocerfyorstSoarlems.onella and Campylobacter